Re-examining links between screen time, health behaviors, and executive functioning: Validating an objective measure of screen exposure in a sample of young children

Project Summary
Researchers argue that the detrimental impact of screen exposure on young children’s development may
depend on the amount of exposure, the type of programming, and the context of use, yet few studies have
attempted to measure each of these variables using naturalistic, observational, and objective methods.
Although extant findings reveal mostly negative associations between screen exposure and outcomes for very
young children across cognitive and socio-emotional domains, the findings have been mixed for school-aged
children. To date, all studies in this area are based on parent report or time-use diaries, which have well-
recognized limitations. No study has used an objective measure of screen exposure across viewing platforms
(i.e., TVs, touch screens, smart phones and computers) in children. Thus, mixed findings in the literature may
be due to measurement issues. Additional research is needed to systematically examine potential adverse
relations between children’s screen exposure and developmental outcomes.
In this proposal, we will validate a novel and objective measure of screen exposure that will assess quantity
and quality of screen exposure using a small wearable camera that has been designed by members of our
investigative team (R21 HD104164). Images will be automatically analyzed for the type of screen and amount
of screen exposure using artificial intelligence algorithms that have been developed by our team. Moreover, we
will characterize specific contextual features surrounding children’s screen exposure such as (a) parental
presence and involvement during screen exposure and (b) whether the programming is continuous or
changing. In addition, this study will be the first to systematically investigate relationships between children’s
screen exposure, their sleep hygiene, and their physical activity using objective measurements of each of
these variables in the child’s home environment. Finally, we will look at associations between quantity and
quality of screen use and individual differences in executive functioning in the same sample of young children.
Participants (n = 230 parent–child dyads) will be drawn from a prospective longitudinal cohort study funded by
NICHD (Brain and Early Experience Study; R01 HD091148); they will be seen one time at 4.5 years of age for
an executive functioning assessment. Families will be provided with devices to measure screen exposure,
physical activity, and sleep in their homes for the following week. Results from this proposed work will validate
the use of our wearable camera as the first objective measure of screen exposure in children and will provide
necessary data for a future R01 proposal to investigate the impact of early screen exposure on the
development of neural networks that are important for executive functions and academic potential in children.

Public health relevance
Project Narrative There are inconclusive findings regarding the influence of screen time on school-aged children’s health outcomes and academic potential; more concrete research is needed on this population. The existence or magnitude of associations between screen time and negative outcomes (e.g, obesity, sleep difficulties, poor cognitive and socio-emotional development) may be limited by the current measurement tools, which have primarily relied on parent report and overlooked other essential information, including contextual factors such as parental involvement and children’s viewing behavior. The proposed study will validate a novel and objective measure of electronic media exposure in young children using wearable cameras that collect, for the first time, screen type and duration of screen exposure over multiple days to better understand links with physical activity, sleep, and executive functioning in young children.